Leadership Administration Core

Leadership Administrative Core
SUMMARY
The objective of the Leadership Administrative Core is to promote the greatest scientific productivity and
educational value by effective management of SCORE resources. The Core will be led by Karen Reue, PhD,
who will work closely with all project and core leaders, as well as the local Scientific Advisory Committee and
External Advisors, to promote an integrated approach to better understand the role of biological sex as a
determinant of risk, development and treatment of cardiometabolic diseases. The aims are as follows:
Aim 1: Provide overall scientific leadership of the SCORE
Aim 2: Ensure effective and efficient administrative management of SCORE resources
Aim 3: Organize an annual Symposium on sex differences and meeting with advisors
Aim 4: To foster collaboration with other SCORE programs and UCLA Women’s Health Organizations
Overall, the Administrative Core will serve a critical coordinating role for all components to promote the most
administratively efficient, and most scientifically productive, program.

Public health relevance
Leadership Administrative Core RELEVANCE TO PUBLIC HEALTH Men and women differ in the prevalence and disease course of common cardiometabolic disorders such as obesity and several cardiovascular diseases. Our investigators are dedicated to understanding the reasons for these sex differences so that both men and women can receive more effective diagnoses and treatments for these conditions.